Disrupted Circadian Regulation of Cell Migration at CNS-Immune Interfaces in Aging and Alzheimer's Disease

Project Summary
6.2 million Americans are living with Alzheimer’s disease (AD), experiencing reduced quality of life and
irreversible deterioration of cognitive function. AD development is likely driven by inflammation in the central
nervous system (CNS), yet there remain no broadly effective therapies. We propose that AD pathology may be,
in part, caused by circadian dysregulation of peripheral immune cell migration through the CNS. The circadian
clock is a critical regulator of biological processes, generating ~24 h rhythms in gene expression, hormone
release, and behavior, but its efficacy in various cells and tissues deteriorates with age. Up to 70% of individuals
with AD experience circadian disruption and sleep-wake disturbances, which often present years before clinical
diagnosis. Circadian dysregulation is therefore a potential biomarker and signal for early intervention in age- and
AD-related pathology. The immune system is tightly regulated by the circadian clock, generating daily cycles of
immune cell migration throughout the body which leads to temporal windows of high and low immune reactivity.
The immune system also critically regulates CNS function; peripheral inflammation disrupts behavior and impairs
cognition. During aging, the CNS immune system gradually shifts from a balance between pro- and anti-
inflammatory function towards a more reactive inflammatory state. Importantly, trafficking of adaptive immune
cells to immune-brain interfaces regulates neuroinflammation and cognition. Thus, we hypothesize that circadian
rhythms in immune cell trafficking to the CNS are disrupted with age and AD-like pathology, leading to cognitive
and behavioral changes. This proposal addresses the following specific aims: First, establish the role of circadian
dysregulation of immune cell trafficking in CNS inflammation and cognitive decline during aging and AD-like
pathology; second, determine if disruption of molecular clocks in key brain-immune interface cells expedites
cognitive decline during aging and AD-like pathology; and third, reveal whether reinstating daily trafficking
rhythms via time-restricted feeding ameliorates age- and AD-induced pathology. This proposal is innovative in
combining expertise in circadian biology, immunology, and behavioral neuroscience to understand how circadian
regulation of brain barriers and immune cell trafficking through the CNS regulates aging and AD-like pathology.
This contribution will be significant because our results will identify how circadian regulation of adaptive immune
cell migration through the CNS affects local neuroimmune function. We expect that our results will identify a
novel role for biological rhythms in regulating neuroinflammatory pathology and cognition via immune cell
migration, highlighting novel therapeutic avenues to target cognitive decline and behavioral changes in aging,
AD, and AD-related dementia.

Public health relevance
Project Narrative Alzheimer’s Disease (AD) is characterized by progressive breakdown in the circadian system, which regulates 24-h cycles in a number of homeostatic processes such as sleep, hormone release, and immune function. The immune system is critically regulated by the circadian system and trafficking of immune cells into the central nervous system is an understudied area implicated in regulating AD. Here we propose to determine circadian regulation of the brain-immune interface, how dysregulation of circadian rhythms contributes to AD-pathology, and whether strategies to boost circadian rhythms protect against brain aging and AD, with the goal of unveiling novel, translationally-relevant insights into the mechanisms mediating AD.